PROTECTIVE CD8 T CELL RESPONSES to TUBERCULOSIS

Project Summary. Mycobacterium tuberculosis (Mtb) is a leading cause of human deaths around the world.
Despite eliciting a vigorous immune response, Mtb evolved to adapt to its host and evade clearance. While this
idea was originally based on its ability to survive in the phagosome and avoid antibody immunity, we now know
that Mtb also avoids T cell immunity. Mtb elicits strong CD8 T cell responses in people and CD8 T cell responses
contribute to protection against Mtb in animal models. My research program has discovered that (1) not all Mtb-
specific T cells recognize Mtb-infected macrophages; (2) CD8 T cells require CD4 help to maintain effector
function and avoid exhaustion; and (3) memory CD8 T cells are not always as fit as naïve CD8 T cells. These
factors contribute to the difficulty in observing a role for CD8 T cells in murine TB. By better characterizing how
CD8 T cells recognize infected macrophages and control Mtb infection, we expect to gain insight into the role
that CD8 T cells serve in immunity to Mtb. My lab has developed an innovative and productive research program
that seeks to understand how CD8 T cells restrict bacterial growth and how Mtb defeats CD8 immunity. Our goal
is to find new ways to elicit protective CD8 T cell responses that can inform vaccine strategies to prevent or treat
TB. In Aim 1, we will combine the use of a BCG prime/ChAd.TB boost vaccine strategy that induces protective
CD8 T cell responses, t-bet fate reporter mice to track memory CD8 T cells, and a novel model of latent TB
infection (LTBI). This approach will permit us to characterize how vaccine-elicited CD8 T cells are recalled
following Mtb challenge, identify protective antigens recognized by CD8 T cells, discover correlates of protection,
and determine the role of CD8 T cells during LTBI. The focus of Aim 2 is disentangle how the lack of CD4 help
and high Mtb CFU lead to dysfunctional CD8 T cells. The molecular differences between helped and unhelped
CD8 T cells will be used to determine the molecular basis of protection mediated by CD8 T cells. We previously
showed that CD8 T cells specific for the immunodominant TB10.4 antigen poorly recognize Mtb-infected
macrophages. However, other CD8 T cells recognize Mtb-infected macrophages and efficiently inhibit Mtb
replication. We have developed an experimental pipeline to identify Mtb antigens presented by infected
macrophages, which we hypothesize will be ideal vaccine targets which will be the focus of Aim 3. Finally, Aim
4 will leverage the differences between protective vs. nonprotective vaccine-elicited CD8 T cell responses (Aim
1), and helped vs. exhausted CD8 T cells (Aim 2), to identify the pathways that license effector CD8 T cell activity,
and perform mechanistic studies that ascertain the pathways that inhibit intracellular Mtb growth. By expanding
our understanding of how effector and memory CD8 T cells participate in immunity to TB, our research program
will provide actionable concepts to incorporate into novel TB vaccine strategies.

Public health relevance
Project narrative. The bacterium Mycobacterium tuberculosis causes the disease tuberculosis and is a leading cause of morbidity and mortality from infection. Infection is usually asymptomatic, but disease develops when the immune system is no longer able to contain the infection. This research proposal seeks understand how CD8 T cells mediate protection to tuberculosis with the goal of informing vaccine development to prevent tuberculosis.